Building sustainable and innovative research in Cancer and Cardiovascular disease: Planning the design and development of the South American Center of Research Excellence to Counter NCDs (SACREN)

SUMMARY OF THE PLANNING UNIT COMPONENT As cancer and CVD are rapidly increasing its disease burden in South America, there is an urgent need to improve their prevention and control strategies, informed by high quality research. Unfortunately, the dearth of adequate population‐based data as well as the limited research infrastructure and funding, challenge NCD research, and particularly cancer research efforts in the region. Since 2010, CESCAS and CRONICAS have assembled two population‐based prospective cohorts formerly funded by NIH/NHLBI until 2014–2015. These cohorts recruited at baseline ~11000 adults randomly sampled from the general population from four cities in Argentina, Chile and Uruguay, and three cities in Peru, respectively. The studies were designed to estimate the prevalence as well as the long term incidence of cardio‐metabolic diseases and their risk factors in adults without CVD at baseline Leveraged a well‐developed research infrastructure, the centers of Argentina and Peru aim to expand their research capacity in cardiovascular epidemiology towards cancer epidemiology, by joining the division of Population Science of DFCI. We will develop a population‐based cancer and CVD research program based on our previous work performed by the centers of Argentina and Peru through their respective prospective cohort studies in Argentina, Chile, Uruguay and Peru, respectively. By integrating these two programs we will be able to identify common risk factors and causal pathways that may influence the development of both CVD and cancer in South America. In addition, we will perform a join pilot project focused on the geo‐mapping of prevalence, incidence and mortality using GIS technology, for Gallbladder and Gastric Cancer. Both cancers have higher incidence in South America, compared to the rest of the world. SACREN will also develop research enhancement activities focused on learning specific knowledge and skills, including hands‐on practice and mentoring, aimed at strengthening the abilities of early‐stage researchers and research support staff. Finally, we aim to identify the shared core facilities each partner will contribute to SACREN to support its research projects, such as data management and analysis, bio banks handling, and communication platforms, exploring mechanisms to share infrastructure and resources to avoid duplication and redundancies, and defining explicitly the rules and regulations for its common use.

Public health relevance
PROJECT NARRATIVE OF THE PLANNING UNIT COMPONENT As cancer and CVD are rapidly increasing its disease burden in South America, there is an urgent need to improve their prevention and control strategies, informed by high quality research. We will develop a population‐based cancer and CVD research program based on our previous work performed by the centers of Argentina and Peru through their respective prospective cohort studies in Argentina, Chile, Uruguay and Peru, respectively. In addition, we will perform a join pilot project focused on the geo‐mapping of prevalence, incidence and mortality using GIS technology, for Gallbladder and Gastric Cancer. Both cancers have higher incidence in South America, compared to the rest of the world. SACREN will also develop research enhancement activities focused on learning specific knowledge and skills and identify the shared core facilities each partner will contribute to SACREN, to support its research projects.